Identification of a novel targetable cancer stem cell regulator promoting cancer progression and metastasis in non-small cell lung cancer

Non-small cell lung cancer (NSCLC) accounts for around 85% of all lung cancer. The
5-
year survival rate is about
14% for stage IIIA NSCLC, while it is about
5% for stage IIIB. However, once
NSCLC has reached to the stage IV
and metastasized to different places, it is very difficult to treat. The
5-
year survival rate for stage IV
NSCLC is
just about 1%. Targeted therapy such as anti-EGFR or anti-ALK is the frontline treatment for advanced NSCLC
with EGFR or ALK mutations, while platinum-based chemotherapy is the first line treatment for advanced
NSCLC without targetable mutations. Interestingly, recent studies suggest that anti-PD1/PDL1 immunotherapy
is a new and effective strategy for advanced NSCLC. While NSCLC patients initially show great benefit from these
treatments, the response is only transient with relatively short duration likely due to acquiring resistant
mechanisms. Identification of novel and effective therapeutic strategies is therefore an urgent need for advanced
NSCLC with metastasis. A small cell population with CSC properties contributes to cancer initiation, progression
and metastasis as well as drug resistance in various cancers such as NSCLC, but an effective strategy to eliminate
CSCs is currently lacking, representing an unmet clinical need for CSC and NSCLC targeting. While CSCs possess
immune escape properties, it is unclear how non-CSC cancer cells accounting for the majority of total cancer cell
populations could also resist from immune cell attack. The goal of this study is to characterize a novel and unique
CSC population in NSCLC and its regulatory mechanisms that can be harnessed for developing a novel effective
strategy for advanced NSCLC and/or for overcoming the resistance to current standard of care. Our study
identifies a novel druggable regulator localized in cell membrane for maintaining CSCs, cancer progression and
metastasis of NSCLCs and its overexpression predicts poor survival outcome NSCLC patients. Genetically or
pharmacologically targeting this newly identified regulator attenuates oncogenic signal for maintain CSC
properties and immune escape leading to cancer progression and metastasis of NSCLC. We hypothesized that a
unique cell population with CSC properties existed in cancer can transmit an oncogenic and immune escape
signal to non-CSC cancer cells, thereby endowing bulk cancer cells with immune escape properties. We proposed
three specific aims, which are highly supported by our innovative preliminary results, to further characterize the
roles and underlying mechanisms of this novel regulator and its ligand as well as their targeting in regulating
CSCs, progression and metastasis of NSCLC. Our proposal is highly original and significant, as we have proposed
a breakthrough concept, identified a novel checkpoint blocker with CSC and immune escape properties and
utilized cutting technologies including unbiased transcriptomics, Cas9/CRISPR editing, patient-derived
organoids, patient derived xenograft (PDX) models, and humanized mice and genetic knockin mouse models
with intact immunity to validate our provocative hypothesis and concept. Our study has revolutionized and
significantly advanced our understanding of CSC and cancer-immune regulation, but also offers a new paradigm
and strategy for targeting advanced NSCLC.

Public health relevance
Advanced non-small cell lung cancer (NSCLC) accounting for 85% of lung cancer is a highly aggressive cancer with poor prognosis and short survival rate. The goal of this study is to characterize a novel and unique cancer stem cell (CSC) population in NSCLC progression and metastasis and dissect its regulatory mechanisms that can be harnessed for developing a novel effective strategy for targeting progression and metastasis of NSCLC and overcoming the resistance to current standard of care treatments. Our proposal represents a paradigm- shifting concept in that the successful implementation of our proposal will not only reveal new insight into CSC regulation leading to cancer progression and metastasis, but also offer a new strategy for targeting advanced NSCLC with metastasis.